Psychiatry Research Residency Training Track

Abstract:
This application responds to PAR-20-094 and seeks renewed R25 support for MH101072, UCSD’s “Psych-
iatry Residency Research Track” (RRT) to stimulate academic psychiatrists to conduct research into the
causes and treatments of mental illness. This R25, first funded in 2013, was renewed in 2018 with a “10”
priority score. In FY 6-9, 100% of the Residents who had “matched” into this RRT in FY1-5 graduated into
“triple threat” positions: 6 are Faculty (5 with Career Development Awards plus significant private funding) and
one is a PGY5 Fellow. Two “internal” trainees joined the RRT mid-Residency. Four of 9 RRT graduates to-date
are from NIH-defined underrepresented groups. A Psychiatry Summer Research Fellowship (SPRF) for URM
Medical Students, funded by this R25, successfully trained future URM Academic Psychiatrists. This renewal
application builds on the strengths of FY1-9 and the scientific expertise of UCSD faculty to sustain an RRT that
is both substantive and innovative. In FY11-15, MH101072 will achieve the goals of the NIMH Council report,
“Investing in the Future,” and of this FOA by expanding the pool of diverse Psychiatric researchers - a key step
towards improving treatment and outcome for mental disorders. This application will achieve 2 Specific Aims:
Aim 1. To recruit and educate the highest caliber future psychiatric researchers. Trainees complete a
4-year RRT; protected research time rises from 17% (PGY2) to 40% (PGY3) to 70% (PGY4), though core
programs effectively extend these percentages. PGY3-4 seminars provide solid grounding in research design,
data analysis, manuscript preparation and responsible conduct of research. Trainees learn academic survival
skills and receive thoughtful supervision and personalized career mentorship. The core curriculum, detailed in
this application, strengthens and sustains trainees' career connection with mental health research and the core
missions of the NIMH. In FY11-15, innovative changes will solidify trainee research funding, build vertical
cohesiveness across the RRT and engage RRT graduates in early career mentorship activities.
Aim 2. To increase the number of research psychiatrists from underrepresented backgrounds.
Diversity among RRT graduates grew from 0% in the 10 years prior to this R25, to 44.4% in the past cycle;
diversity recruitment will expand in FY11-15. The SPRF for URM medical students added 6 URM trainees to
Psychiatry Residencies, including 2 to RRT’s; 2 more SPRF trainees still in med school are headed into
Psychiatry. This renewal builds on this success by doubling the size of our SPRF to 4 trainees per Summer.
With renewed support, MH101072 will admit 10 new RRT trainees, graduate 9 trainees (5 current + 4 new),
leaving 8 trainees “in the pipeline” to complete their training via renewed R25 or DoP support. This will bring
the total yield of MH101072 (FY1-15) to 30 RRT graduates, in addition to 36 URM Summer Fellows. This RRT
will provide individualized oversight of each trainee in an innovative format that will accelerate their paths
towards faculty positions and career research funding and thereby achieve the goals of this NIMH program.

Public health relevance
Project Narrative Mental health problems are responsible for a significant public health and socio-economic burden in the US. A shortage of research psychiatrists threatens future advances in the prevention and optimal treatment of mental illness. This application renews support for a psychiatry research residency track that nurtures the early career advancement of a diverse group of research psychiatrists, and provides them with the expertise needed to most effectively advance our understanding of the causation of mental health problems and the development of novel therapeutic strategies.